NEI Center Core Grant for Vision Research

SUMMARY
Overall
The overall purpose of the Center Core Grant for Vision Research is to provide core services and resources
to enhance and accelerate the productivity and impact of the vision research community at the University of
California, San Diego. Specifically, the Center Core Grant for Vision Research will leverage the outstanding
basic science and clinical research expertise of National Eye Institute funded investigators by providing
important resources and services organized into the following five distinct cores.
1. The Vision Biostatistics Core provides dedicated statistical expertise for the vision research community at
UCSD. There are several common analysis themes and statistical issues that can be addressed effectively
and efficiently by having a dedicated biostatistician familiar with eye research to analyze vision-related data
and to ensure rigor and transparency of the results.
2. The Animal Structure and Function Core will provide shared instrumentation and a technician to assist
with ocular structural imaging and functional imaging in animals.
3. The Computational Ophthalmology and Biomedical Informatics Core provides i) dedicated high-
performance CPU and GPU computing resources ii) 3 computer programmers, iii) institutional software
licenses, iv) electronic health record data extraction services, v) cloud-based data management
infrastructure, and vi) secure file sharing and backup services to support UCSD’s cellular, animal and
human vision research studies.
4. The Histology, Tissue Processing and High Content Microscopy Core provides rapid characterization of
eye tissue with respect to histology, immunohistochemistry and high content microscopy for drug screening
and histologic specimen imaging by supporting instrumentation and a technician who is familiar with ocular
anatomy and techniques required to properly process ocular tissues.
5. The new Viral Production and CRISPR Engineering Core provides centralized dedicated space,
equipment and personnel for the production, isolation and titering of adeno-associated virus (AAV) and
lentivirus (LV) vectors and assistance with non-viral CRISPR gene editing.
These cores will improve the efficiency and productivity and impact of UCSD vision scientists by providing
core services that are unavailable or not easily accessible to individual investigators. The core grant
infrastructure and resources also leverage the expertise of each participating investigator to enhance
multidisciplinary collaboration for the benefit of the entire UCSD vision research community.

Public health relevance
NARRATIVE Overall The UCSD Center Core Grant for Vision Research will provide core services and resources to enhance and accelerate the productivity and impact of vision research at UCSD. These resources will be used to foster collaboration among faculty from the Jacobs School of Engineering, Halicioglu Data Science Institute, Institute for Genomic Medicine, and the Departments of Ophthalmology, Neurosciences, Biomedical Informatics, Pharmacology and Psychology to bring us closer to our goal of the prevention and cure of blinding eye diseases such as glaucoma, macular degeneration and diabetic retinopathy.